2024 Bioinspired Materials Gordon Research Conference and Seminar

Project Summary/Abstract
The emerging, interdisciplinary field of bioinspired materials focuses on developing a fundamental
understanding of the synthesis, self-assembly, hierarchical organization, and function of naturally occurring
materials and uses this understanding to develop artificial materials for a broad range of applications, including
the delivery of therapeutics, tissue engineering, and living materials. Many of these topics are of significant
interest to NIBIB. The Gordon Research Conference (GRC) on Bioinspired Materials, which will take place
June 16-21, 2024 at the Les Diablerets Conference Center in Les Diablerets, Switzerland, seeks to capture the
excitement of this burgeoning field with a cutting-edge scientific program and a diverse roster of invited
speakers and discussion leaders that includes distinguished experts and novices to the field, in the unique
format of a Gordon Conference that guarantees an intimate cross-fertilization of ideas. The conference is
intended to focus on unpublished data, define new directions in the discipline, and create a cohesive
community by promoting interactions between early-stage investigators and established senior investigators.
More than half of the program of the 2024 GRC on Bioinspired Materials meeting is devoted to the
development and application of novel materials that focus on applications to human health. In the preliminary
program, 36% of the confirmed speakers are women, 20% are early-stage investigators, and we estimate that
28% belong to UM groups. The aims of the conference are to: 1) Provide a platform for the exchange of
cutting-edge work on Bioinspired Materials and their applications, including therapeutics, tissue engineering,
and living materials; 2) Bring together a diverse group of speakers that include widely acknowledged thought
leaders and early-stage investigators; 3) Promote cross-disciplinary fertilization of new ideas in the format of a
GRC, which is a unique mixture of formal oral presentations, in-depth discussions, and informal networking in
an intimate setting; 4) Create a sense of community by promoting interactions between young scientists and
early-stage investigators with prominent senior investigators through oral and poster sessions, and through
informal interactions such as social activities during the afternoons and evenings; 5) Nurture future researchers
of the field by offering a Gordon Research Seminar (GRS), which will precede the GRC (June 15-16, 2024)
and will offer students and postdocs with comparable levels of education and experience the opportunity to
gather, present and discuss their research findings; 6) Encourage inclusion and diversity in the bioinspired
materials community through an inclusive conference, as well as a Power Hour – a unique platform found at
GRCs - devoted to discussing strategies for the advancement of women and members of underrepresented
minority groups in bioinspired materials science. The support requested from NIH will be used to cover portions
of the international travel and registration of US graduate students, postdocs, early-stage investigators,
women, and members of underrepresented minority groups to participate in the GRC and GRS.

Public health relevance
Project Narrative The 2024 Gordon Research Conference on Bioinspired Materials will be held June 16-21, 2024 in Les Diablerets, Switzerland, and will be preceded by an accompanying Gordon Research Seminar (June 15-16, 2024). The program focuses on current, cutting-edge advances in the area of bioinspired materials, with a specific emphasis on the delivery of therapeutics, tissue engineering, and living materials. As a GRC conference, the meeting will emphasize unpublished work, provide a setting for personal scientific exchanges, and accommodate a diverse group of speakers and attendees.